Internet Connection for Providence Family Physicians

DESCRIPTION (provided by applicant): The overarching goal of this project is to improve the quality of health care services delivered to the residents of rural Citronelle, Alabama. Specific aims are as follows: 1. Purchase and install hardware and software that will support high-speed Internet service and network connectivity between Providence Family Physicians - Citronelle (19140 South 3rd Street, Citronelle, AL 36522) and Providence Hospital's Data Center (6701 Airport Boulevard, Mobile, AL 36608) within two months of grant award 2.Train the physician and the four staff members in use of the high-speed Internet service within two weeks of completed installation and provide technical support services as needed throughout the project period. Providence Family Physicians, a network of 11 family practice centers, is a division of Seton Medical Management, a nonprofit organization. Seton Medical Management and its parent organization, Providence Hospital, nonprofit subsidiaries of Ascension Health. Established in 1854 by the Daughters of Charity, Providence Hospital, a member of Ascension Health, has grown from a 60-bed, center-city infirmary to a 349-bed full service hospital serving southwest Alabama and southeast Mississippi. Its mission is to remain true to its reputation as a values-driven health system that services the health needs of the total individual - body, mind, and spirit. This project will further Providence Hospital's longstanding tradition of ensuring access to high-quality health care to all individuals.